Development and Assessment of Live Microbiome-Based Products: Fecal Microbiota for Transplantation (FMT) and Live Biotherapeutic Products (LBPs)

To support the development and assessment of two live microbiome-based products - Fecal Microbiota Transplant (FMT) and Live Biotherapeutic Products (LBPs).